Pilot & Feasibility Program

Pilot Project Summary/Abstract
The mission of the Pilot and Feasibility (P&F) Program is to foster the development of new investigators and to
provide seed support for innovative diabetes-related research. Over the past 10 years, we have funded 64
outstanding projects. Over 90% of these were from young investigators looking to establish new independent
research programs. More than 95% of our P&F recipients are still active in research, providing clear evidence
that we are selecting meritorious recipients. Moreover, our funded investigators have an impressive record of
obtaining post-P&F NIH grant support and of publications in high-impact journals. Most importantly, many
awardees are now productive R01-funded faculty members at UCSD/UCLA or at other institutions. Going
forward we propose to fund 5-6 grants each year to facilitate the generation of preliminary data sufficient to
support R01 grant applications. We strive to identify proposals with translational impact when possible. The
P&F Program will promote innovative diabetes projects, catalyze the development of future scientific leaders,
mentor recipients to facilitate their transition to external funding, leverage institutional matching support,
synergize with institutional training h programs, promote inclusion of young investigators from diverse
backgrounds, foster collaborations, and implement oversight and programmatic review of the program and its
awardees.